West Virginia IDeA Network of Biomedical Research Excellence (WV-INBRE)

West Virginia has a history of a low success rate in obtaining grant funds from the National Institutes of Health and has been designated as an IDeA state. In this renewal application, Marshall University (MU), in partnership with West Virginia University (WVU), will continue to build on the success of the West Virginia IDeA Network of Biomedical Research Excellence (WV- INBRE) to help develop biomedical research infrastructure and capacity throughout the network and provide biomedical research experiences for undergraduate and graduate students from the research network institutions. MU, in partnership with WVU, will continue to serve as lead institutions to a research network consisting of eight primarily undergraduate institutions (PUIs) and nine community colleges. The multi-disciplinary theme for WV-INBRE will be cellular and molecular biology. Supporting the activities of the network will be the Administrative, Data Science and Sequencing, Molecular and Related Technologies (SMART) Cores which have been established to facilitate research progress, mentoring and training, and career development of investigators and students at the lead and research network institutions. Research in the network will be supported by Research Projects (major PUI research awards) and Pilot Projects (e.g. Faculty Research Development Awards (FRDAs), Center for Natural Products Research Pilot Awards) through the Developmental Research Projects Program. Ties to WV COBREs and the WV IDeA-CTR (WVCTSI) will be expanded. Proposed Student Research Program activities will provide several research opportunities for PUI students. A new initiative with the Puerto Rico INBRE in natural products research will provide summer student exchanges, co- hosted regional virtual symposia, and research collaborations. Through providing workshops, seminars, research training and mentoring, and access to state-of-the-art core facilities, WVINBRE will help enhance the science and technology knowledge and skill base of the WV workforce.

Public health relevance
WV-INBRE supported research projects will investigate several major human health issues that are particularly prevalent in West Virginia including cancer, cardiovascular disease, diabetes, obesity-related illness and addiction. An important aspect of WV-INBRE is directed toward enhancing the pipeline of undergraduate and graduate students choosing a career in the biomedical science research field.